Engineering Oral Tumor Microcirculation: Blood and lymphatic capillary network-enabled Human Oral Tumor Microenvironment Chips for Preclinical Research

ABSTRACT
Engineering Oral Tumor Microcirculation: Engineering blood and lymphatic capillary network-enabled
Human Oral Tumor Microenvironment Chips for Preclinical Research
Oral squamous cell carcinoma (OSCC) is a highly aggressive cancer with limited treatment options and poor
survival rates, primarily due to our incomplete understanding of its tumor microenvironment (TME). Key
processes such as angiogenesis, lymphangiogenesis, and vasculogenesis are pivotal to tumor growth, immune
response, and metastasis but remain underexplored in OSCC research. Current tumor models lack the
complexity required to mimic these vascular dynamics, impeding the study of tumor-endothelial crosstalk and
the microcirculatory transport of immune cells, platelets, and therapeutic agents. To address this challenge, we
propose the development of advanced tumor microenvironment chips (TME-chips) that incorporate perfusable
blood and lymphatic capillary networks. These innovative systems, designed to recreate OSCC’s TME with
unprecedented accuracy, will integrate 3D tumor spheroids and allow for simultaneous modeling of
angiogenesis, lymphangiogenesis, and microcirculatory dynamics. Here, we aim (1) to engineer TME-chips with
functional blood capillary networks to explore the roles of tumor-driven angiogenesis and therapeutic responses,
and (2) to develop lymphatic capillary network-enabled TME-chips to investigate the mechanisms of tumor
metastasis and lymphatic transport. By combining advanced microengineering with cutting-edge cancer biology,
this project will provide a platform to unravel the complex interactions driving OSCC progression and resistance
to therapies. The proposed research is significant in its potential to transform OSCC modeling, offering insights
into vascularized tumor environments that were previously unattainable. By bridging critical knowledge gaps,
these TME-chips will serve as powerful tools for preclinical drug testing, biomarker discovery, and the design of
more effective therapeutic strategies, ultimately addressing an unmet need in OSCC research and patient care.

Public health relevance
PROJECT NARRATIVE This research is relevant to public health because the development of this microcirculation-enables oral cancer- chip technology is ultimately expected to increase the understanding of the biology of cancer, as well as predict the response to drug candidates to the extent that it motivates downstream preclinical and clinical studies. This will be the first instance that the proposed methodology will contain fully perfused blood and lymphatic capillary networks. Therefore, this is most relevant to promoting the FDA Modernization Act 2.0 passed by the US Senate and the NIH funding criteria that pertains to reducing/replacing animals with new and transformational biomedical research techniques.